Babson Life Sciences Entrepreneurial Product Development Immersion for New Technologies and Solutions (Babson L-SPRINT) Program

Project Summary/Abstract
The ability to coordinate or match drug addiction scientists with business, regulatory, and financing experts
(referred to as ‘entrepreneurial leaders’) is key to establishing societal and commercial solutions in this subject
area. Having a database to search for specific characteristics or knowledge, and a platform to identify and
introduce potential partners in is expected to lead to longer associations and startup success. SUD companies
may require some different skill sets, e.g., public health’s focus on the social determinants of health, or public
finance and non-profit management, and thus finding a way to match academic researchers with entrepreneurial
leaders interested in startups that tackle drug addiction is key to establishing successful ventures.
We will also generate and track possible measures of success including networking metrics and publish findings
on these associated metrics. Again, with specific reference to SUD ventures, we will hypothesize metrics that
may be associated with success and publish the empirical data found to be most important for startup success
in drug addiction.

Public health relevance
Project Narrative The ability to coordinate or match drug addiction scientists with business, regulatory, and financing experts (referred to as ‘entrepreneurial leaders’) is key to establishing societal and commercial solutions in this subject area. Having a database to search for specific characteristics or knowledge, and a platform to identify and introduce potential partners in is expected to lead to longer associations and startup success. We will also generate and track possible measures regarding networking success between scientists and entrepreneurial leaders and regarding SUD startup successes and publish findings forthwith.